Molecular mechanisms of axon guidance receptor regulation and signaling

PROJECT SUMMARY
Determining how neurons are correctly specified and assembled into functional circuits will provide
insight into developmental disorders of the nervous system and may suggest therapeutic approaches to
promote nerve regeneration. Slit and Netrin, and their Robo and Fra/DCC receptors, are evolutionary
conserved families of signaling molecules that play important roles in regulating neuronal development;
however, the understanding of how these receptors are regulated and how they signal to direct axon
growth and guidance is incomplete. These are important questions because perturbations of these
signaling pathways are implicated in diseases of nervous system development. Slits, Netrins and their
receptors also play essential roles outside of the nervous system and disruptions of these pathways are
associated with several kinds of cancer. Our research program focuses on three broad areas related to
the roles and regulation of these molecules in neuronal development using the genetically tractable
Drosophila embryonic nervous system as a model. First, we are working to define functional and
molecular links between conserved transcriptional regulators that impart neuronal subtype identity and
the Robo and Fra/DCC receptors that coordinate axon guidance and dendrite morphogenesis in
response to Slit and Netrin. Here, we will use genetic and molecular screening approaches, including
Fluorescence Activated Cell sorting (FACs) of defined subsets of motor neurons, together with
transcript profiling in wild type and mutant backgrounds, to systematically identify additional effectors of
these transcriptional programs. Second, we are characterizing a newly discovered mechanism through
which the Frazzled/DCC receptor intracellular domain (ICD) itself can act in the nucleus as a
transcriptional activator to regulate commissureless expression to ensure that commissural axons avoid
premature responses to midline repellent Slit. Here, we will use genetic and molecular approaches to
identify factors that cooperate with the Fra ICD to regulate transcription and transcript profiling methods
to identify additional targets of the Fra ICD. In addition, we will explore whether signaling from the
nucleus is a common property of axon guidance receptors and through collaboration we will test if this
is a conserved property of guidance receptors. Third, we are determining the molecular mechanisms
underlying Robo and Fra/DCC receptor signaling during axon guidance using molecular, genetic,
biochemical and cell biological approaches. Specifically, we use in vivo genetic manipulation, together
with fluorescently tagged receptors and reporters of signaling molecule activity in vitro, to define the cell
biological outputs of receptor activation with sub-cellular resolution. Our research program will define
new concepts in the molecular biology of axon guidance, inform studies of related proteins in
mammalian systems and will likely enhance our understanding of neural developmental disorders.

Public health relevance
PROJECT NARRATIVE Understanding how neurons are correctly assembled into functional circuits will provide critical insight into developmental disorders of the nervous system and may inform strategies to promote neuronal repair in cases of injury or disease. The current knowledge of the molecular genetic pathways that control neuronal development is incomplete. Our research program addresses three major questions related to the assembly of neural circuits: 1) How do transcription factors that control neuronal subtype identity coordinate the expression of axon guidance molecules that control wiring specificity? 2) What are the signaling mechanisms that allow conserved families of guidance receptors to control direction-selective axon growth and targeting? 3) How do navigating axons coordinate their responses to the diverse array of cues present during development to ensure assembly of functional circuits? Disruption of the function of many axon guidance molecules has been implicated in a number of human neuronal developmental disorders, as well as in various kinds of cancer. Thus, understanding the signaling mechanisms of these molecules in the context of normal development will be instrumental in understanding how their perturbation leads to pathogenesis.